Development of a Treatment for Eosinophil-Mediated Allergic Inflammatory Diseases Utilizing a Neutralizing Agent Targeting Eosinophil Granule Major Basic Protein

ABSTRACT
The eosinophil is a peripheral blood leukocyte containing an abundance of cytoplasmic granules, rich in cationic
protein toxins. Among these, the most abundant on a molar basis is the major basic protein-1, eMBP1. eMBP1
kills helminths, bacteria, and numerous cells, such as respiratory epithelium, but also activates cells, including
basophils and mast cells. Studies of human diseases show that eMBP1 is present in secretions from patients
with eosinophil-mediated diseases, including asthma, chronic rhinosinusitis, and gastrointestinal diseases, and
it is deposited on damaged targets. These studies show that the eosinophil mediates its damage to parasites
and tissues by discharging its toxin rich granules onto microbial targets and tissues. eMBP1 is synthesized as
a precursor, pro-eMBP1, composed of eMBP1 and a remarkably acidic pro-piece sequence. Developing
eosinophils synthesize pro-eMBP1, and the pro-piece is removed during granule maturation. Analyses of pro-
piece in different models show that it can neutralize the toxic eMBP1 effect and also the toxicity of the eosinophil
cationic protein (ECP). This project proposes that neutralization of eMBP1 can be a treatment to mitigate tissue
damage in eosinophil-related diseases. It will develop a pro-piece product for treatment of eosinophil-mediated
diseases by neutralization of eMBP1 and other granule toxins. Currently, no therapies for these diseases
address the neutralization of granule proteins.
In this project, the pro-piece will be expressed and associated glycans will be modified to identify the optimal
form of the molecule for binding to and neutralizing eMBP1. These tests will determine whether glycosylation of
pro-piece importantly alters its binding to eMBP1 by analyzing whether N- or O- glycans and the
glycosaminoglycan at S62 modify its activities. The project will identify the most important pro-piece regions for
binding eMBP1 and neutralizing it by creating overlapping peptides and creating mutants with increased amino
acid sequences characteristic of active regions. Evaluation of the pro-piece panel for binding to and inhibiting
eMBP1 will be evaluated here in several in vitro models. The goal of this project is to identify an active form of
the pro-piece with optimal inhibition effects on eMBP1 and other granule toxic proteins. This form will be further
investigated and developed in future projects.

Public health relevance
Narrative The eosinophil, a type of immune cell in the blood circulation, presently is known to cause damage in various diseases, including asthma, chronic sinus inflammation, gastrointestinal disorders, and allergic inflammation. This proposed project is directed at developing a treatment to neutralize toxic products from eosinophils that contribute to these diseases. A successful completion of this project has the potential to treat a wide range of eosinophil-mediated diseases and improve the lives of a large population suffering from them.